RESOURCE CORE: Penn State University's Translational Center for Child Maltreatment Studies (TCCMS)

RESOURCE CORE: PROJECT SUMMARY / ABSTRACT
Ensuring that the empirical, scientific, applied, and community-engagement components of Penn State's
Translational Center for Child Maltreatment Studies (TCCMS) are successful is the primary goal of the
Resource Core (RC). The RC will be devoted to supporting the proximal needs of all TCCMS Projects and
Cores through personnel, expertise, administrative supports, and research tools (Aim 1), as well as distal
needs through an innovative communications plan that introduces an integrated, modern framework for
translating and communicating information and tools to the public and the larger field (Aim 2). This
communications plan will (1) create an environment where new networks and partnerships of scholars,
trainees, practitioners, and community members can be facilitated, (2) be a hub of scientific information and
evidence-based tools for anyone who is in search of the latest innovations CM research, policy, and practice,
and (3) institute a communications system that will alert the professional and lay communities to the best and
most up to date information in the CM field. Before information can be disseminated, it must first be effectively
translated to meet the needs of the audiences it intends to impact. As such, the RC will create a CM
information Translation Team (TT) comprised of investigators and trained communications professionals who
will compile, organize, and synthesize research findings into translational messages that resonate with
stakeholder needs and specifications. These translational products will then be handed off to an experienced
Communications Team (CT) who will disseminate them widely via the RC communications platforms. These
platforms include a “gateway” website that will house (1) the science warehouse where relevant, evidence-
based science and practice tools are curated, catalogued, and stored, (2) the policy warehouse where TCCMS
policy products as well as news and information about major CM policy and practice reforms from across the
US are showcased, and (3) the member forum which engages followers and members in active discourse
regarding major scientific issues and advances from across the field. These platforms will also include
listserves, newsletters, email, and all relevant forms of digital media that are strategically positioned for
maximum reach and impact.
The RC is guided by the following 2 Aims:
Aim 1: By overseeing and administering shared resources included in the RC as well as resources provided by
the impressive institutional match commitment from Penn State, the RC will provide the staff, expertise, and
other research support to meet the proximal needs of TCCMS Projects and Cores.
Aim 2: The RC will provide the staff and expertise that will locate, translate, and share the products and
activities of the TCCMS (and across the field) to the public and the larger CM field via innovative
communications platforms.